Elucidating the mechanism of Ga13 mediated tumor suppression in pancreatic cancer

RESEARCH SUMMARY
The heterotrimeric G proteins transduce signals from the G protein-coupled receptors (GPCRs), the largest class
of cell surface proteins that regulate a wide variety of biological processes. Gα13, a member of the G12 family
of heterotrimeric G proteins, has been reported to be a tumor suppressor or promoter in different tumor contexts.
We recently reported that loss of Gα13 accelerated tumor development and reduced survival in a well-
characterized genetic mouse model of pancreatic cancer. Mechanistically, Gα13-deficient mouse pancreatic
tumors had elevated mTOR signaling, similar to human pancreatic cancer. Consistently, tumors derived from
Gα13-deficient pancreatic cancer cells were susceptible to rapamycin, a well-characterized mTOR inhibitor.
Recently, we have shown that loss of Gα13 in pancreatic tumors and cancer cells increased mitochondrial
metabolism and expression of inflammatory cytokines. However, the impact of tumor metabolism and
inflammation on the development and progression of Gα13-deficient tumors and whether mTOR signaling
regulates these processes has not been investigated. Our objective in this application is to elucidate the
mechanism(s) by which the deletion of Gα13 in the pancreas cancer cells contributes to tumor development and
progression in vivo. The central hypothesis is that loss of Gα13 promotes tumor development through elevated
mTOR signaling to drive mitochondrial metabolism and inflammation. Two specific aims are proposed: 1)
Determine whether mTORC1 signaling is necessary for promoting cellular metabolism of Gα13-deficient pancreas
tumors. 2) Determine whether mTORC1 signaling is essential in mediating the increased inflammation in Gα13-
deficient tumors. In Aim 1, we will determine whether inhibition of mTORC1 signaling delays tumor development
and induces cell death in early and advanced tumors lacking Gα13. Further, we will assess how Gα13 loss
regulates tumor metabolism and whether Gα13-deficient tumors are susceptible to perturbations of mitochondrial
functions. In Aim 2, we will determine whether Gα13 loss increases inflammatory cytokine levels and tumor-
promoting immune cells in early and advanced tumors. We will determine whether blocking mTORC1 signaling
limits the expression of candidate cytokines and immune cell infiltration to suppress tumor growth in Gα13 lacking
tumors. Finally, we will examine whether combining anti-inflammatory agents with inhibitors of mitochondrial
function will synergistically enhance anti-tumor efficacy. The innovative component of this proposal is the use of
a unique mouse model to study the tumor suppressive function of Gα13, where the loss of the gene in both
human and mouse pancreas tumors correlates with elevated mTOR signaling and worse survival outcome. We
will also use the innovative approach of human tumor slice culture assays to determine whether Gα13 status
dictates the response to inhibition of mTORC1 signaling. The proposal is significant because it will elucidate the
tumor suppressive mechanisms of Gα13 in pancreatic cancer, providing insights into beneficial therapies for
patients with Gα13 deficiency.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is an aggressive disease with limited treatment options. We find that Gα13, a signaling mediator of G protein coupled receptors (GPCRs) which are major target of approved drugs, regulates mTORC1- mediated tumor metabolism and inflammation. In this proposal we will determine whether Gα13 status determine the susceptibility to perturbations of metabolism and inflammatory mediators.